High-resolution Non-cryogenic Magnetoencephalography: Systems-Level Integration

Abstract
Magnetoencephalography (MEG) is an important functional neuroimaging technique that provides an
excellent combination of high spatial and temporal resolution. At present, MEG scanners are handicapped
by cost and complexity imposed by cryogenically cooled superconducting sensor technology. In our recently
completed Phase II project, we developed new noncryogenic optical sensors that are suitable replacements
for superconducting sensors in MEG systems.
In this project, using our newly developed sensors, we will build a low cost, room temperature, ‘wearable’
MEG system with resolution exceeding current gold standards. The system developed in this project will be
an advanced commercialization ready prototype suitable for neuroscience research applications.

Public health relevance
Project Narrative National Institute of Mental Health estimates from 2016 suggests around 44.7 million people over the age of 18 suffer from mental illness. The technology development in this project will lead to a step-change in our ability to understand how the brain works, diagnose, and treat mental disorders.